Determining the Sources of Motor-Cortex Response Complexity

PROJECT ABSTRACT
Motor cortex is the brain area most responsible for voluntary movement. In humans, damage to motor cortex or
its outputs – for example due to stroke or disease – causes profound and often permanent movement deficits.
Treating dysfunction, or finding ways to bypass it, requires a principled understanding of normal function.
Fundamental to that goal is the need to characterize the relationship between motor-cortex neural activity and
movement. Attempts to do so must contend with a striking feature of motor cortex neural responses: their
complexity and heterogeneity. Motor cortex responses are floridly multiphasic and remarkably diverse. Each
recorded neuron has a unique response pattern, different from the last hundred neurons one observed.
Attempts to understand motor cortex computation must therefore embrace, and hopefully explain, response
complexity. Our field was initially resistant to this path – response complexity seemed like a bug rather than a
feature. Yet as the nature and extent of response complexity became inescapable, hypotheses have
increasingly sought to explain complexity as a natural consequence of the ‘job’ performed by motor cortex.
Three possible sources of response complexity have been considered: (1) representation of many movement
parameters, (2) biomechanical complexity, and (3) complexity of neural dynamics in which motor cortex
participates. While all three sources presumably contribute, current hypotheses make very different
assumptions regarding which source predominates. Distinguishing amongst these hypotheses – and informing
new ones – has been difficult for a straightforward reason: most laboratory tasks engage all three sources of
complexity. To make headway, we combine multiple innovations. These include very large-scale neural
recordings (using many Neuropixels probes simultaneously) and recordings of motor-unit (MU) populations
from the muscles. Critically, we leverage a novel task that minimizes physical complexity while maintaining – or
even increasing – the complexity of internal computations needed for accurate performance. We use recently
developed analysis tools that are ideally suited to addressing the central questions, and will compare results
with network models that embody competing hypotheses. The resulting datasets are expected to be unusually
rich, and thus capable of both testing current hypotheses and informing new ones.

Public health relevance
PROJECT NARRATIVE In humans, damage to motor cortex or its outputs causes profound and often permanent movement deficits. Treating dysfunction, or finding ways to bypass it using a brain-computer interface, requires a principled understanding of normal function. The goal of this proposal is to use novel experimental approaches to illuminate how neural activity in motor cortex subserves the generation and control of our movements.